Building AMR monitoring capacity through expanding NGS capabilities

PAR-18-604 Vet-LIRN Network Capacity-Building Project
Michigan State University
Project Title: Building AMR monitoring capacity through expanding NGS capabilities
Project Summary/Abstract
The overall objective of this proposal is to enhance the Michigan State University Veterinary
Diagnostic Laboratory (VDL)’s capability and capacity for surveillance of antimicrobial resistance
(AMR) in pathogens deemed to be of high consequence for both animal and public health. The
VDL is a full-service veterinary diagnostic laboratory staffed and equipped to provide complete
pathological, microbiological, molecular testing for FDA, CVM, and federal, state, or local
agencies. The 150 VDL faculty and staff run more than one million tests a year on samples from
all 50 states and more than 25 countries.
The VDL is in the process of expanding its next generation molecular testing capabilities for
diseases affecting domestic and wildlife species of Michigan. For several years, the VDL has
maintained ongoing collaborations the Veterinary Laboratory Investigation and Response
Network, FDA (Vet-LIRN) to support WGS of bacterial isolates as part of the national initiative to
Combating Antibiotic Resistant Bacteria (CARB).
Given the MSU VDL’s high caseload of companion animal cases from Midwest and across the
United States, the laboratory is uniquely poised to support local, regional, and national AMR
surveillance activities. The MSU VDL sees a significant number of antibiotic-resistant
Pseudomonas aeruginosa and Enterococcus faecalis and Enterococcus faecium as part of our
routine caseload, all considered to be leading causes of resistant infections in these animals.
These infections have important animal and public health impacts, given the frequency of
treatment failure and the potential for zoonotic transmission in these cases. Using the VDL’s
recently expanded next-generation capabilities both in terms of equipment (NextSeq 1000) and
staff, the VDL is prepared to perform WGS on up to 400 bacterial isolates (roughly 200
pseudomonas and 200 enterococcus). The addition of additional equipment (QuBit and OT-2
NGS Workstation) will allow for more rapid, higher-throughput and more cost-effective
sequencing. The data generated will help track the antibiotic resistant genes in these bacteria
and monitor for new resistant traits. Comparing the sequence data to phenotypic resistance
data and clinical data (when available) can be used to predict treatment outcomes.

Public health relevance
PAR-18-604 Vet-LIRN Network Capacity-Building Project Michigan State University Project Title: Building AMR monitoring capacity through expanding NGS capabilities Project Narrative The primary goal of this project is to implement the use of additional equipment to increase throughput, speed, and cost-effectiveness of our bacterial whole-genome sequencing (WGS) process, through purchase and implementation of a QuBit flurometer and a OT-2 next- generation sequencing (NGS) Workstation. Our second goal is to leverage the new equipment to support local national and regional antimicrobial resistance surveillance efforts; we intend to perform identification, sensitivity testing, and WGS on up to 400 bacterial isolates (200 Pseudomonas and 200 Enterococcus). The MSU VDL enhanced capabilities will be for routine diagnostic testing in support of animal health, Vet-LIRN initiatives and in support of human health (zoonotic risks) investigations with other Federal, state and local agencies.